Developmental control of replication initiation and genome stability

Project Summary
Every cell division requires the faithful duplication of genetic material from
mother cell to daughter cell. Defects in the proper execution of the DNA
replication program can directly result in the genome instability that is a hallmark
of nearly all cancer cells. To ensure genome stability, the machinery responsible
for DNA replication must be highly regulated. There must be enough flexibility
built into the DNA replication program, however, to accommodate the dramatic
changes in cell cycle and S phase progression that occur during the development
of an organism. Understanding this regulation is imperative to determine how
genome stability is maintained during development.
We utilize the powerful developmental systems available in Drosophila to
identify key regulators of the DNA replication program, with the ultimate goal of
delineating the molecular underpinnings responsible for regulating genome
duplication and stability during development. Our main focus is understanding
how replication initiation is regulated to ensure genome stability. We have
defined three key projects where the strength of our system positions us to make
key insights. These include: 1) understanding the functional relationship between
nuclear pore proteins and the Origin Recognition Complex (ORC). 2) Defining the
key targets and molecular mechanisms Rif1 uses to influence replication initiation.
3) Identifying and characterizing posttranslational modifications of ORC that
affect replication initiation.

Public health relevance
Project Narrative Adversity experienced during childhood is associated with an increased risk of developing many of the most common diseases of aging in adulthood, such as obesity, cognitive impairment, and cardiovascular disease. This project will address how DNA methylation contributes to the observed relationship between adverse childhood experiences and adult-onset diseases that involve diverse organ systems, by identifying DNA methylation variation associated with early life adversity in a multi-tissue dataset and determining its functional importance through associations with gene regulation. This project will provide insight into how social determinants of health “get under the skin” to contribute to disparities in age-related disease, with the potential to contribute to the future design of intervention strategies.